Gout Epidemiology in Chronic Kidney Disease: Transition to End-stage Kidney Disease and Impact of Renal Transplant

PROJECT SUMMARY
Gout coexisting with advanced chronic kidney disease (CKD) poses a complex and under-researched
medical challenge. There is scant evidence and an important knowledge gap to guide gout management in
patients transitioning from advanced CKD to end-stage kidney disease (ESKD), where dialysis or kidney
transplantation (KT) becomes necessary. Understanding the burden of gout during the transition from non-
dialysis CKD to ESKD and subsequently to KT is essential for optimizing treatment strategies and improving
patient outcomes. This research, utilizing data from the United States Renal Data System (USRDS), aims to
explore the evolution of gout burden (including flares and healthcare utilization) from advanced CKD to ESKD,
and for those undergoing KT.
Our overarching goal is to test the central hypothesis that individuals with concomitant gout and CKD
progressing to dialysis (ESKD) will have an increased burden of gout (flares, emergency room visits,
hospitalization, and cardiovascular disease) during the period of transition into dialysis. In addition, gout burden
after kidney transplantation has decreased after the transition of anti-rejection regiments to those not using
cyclosporine (primarily) and calcineurin inhibitors in general. We will test this hypothesis using data from the
United States Renal Data System (USRDS) and the United Network for Organ Sharing (UNOS). For this, we will
apply a self-controlled case series (SCCS) method, where individuals act as their own controls, reducing the
influence of between-person confounding variables. We will also conduct a retrospective cohort study examining
the change in the incidence of gout, immunosuppressive regimes, and related patient outcomes in Kidney
Transplantation.
The two aims will rigorously evaluate the natural history of the gout burden in critical phases of CKD and
ESKD . The goal of Aim 1 (CKD to ESKD aim) examine the trajectory of gout burden and treatment
patterns as patients transition from advanced CKD to ESKD. The goal of Aim 2 (Kidney transplantation
aim) is to assess changes in gout incidence, gout flares, and outcomes including cardiovascular hospitalizations
and mortality among KT recipients.

Public health relevance
PROJECT NARRATIVE Gout frequently coexists with advanced chronic kidney disease (CKD), dialysis, and kidney transplant and there is scant clinical evidence in these populations to inform clinical trials, drug development, implementation research, and treatment guidelines. We will utilize data from the United States Renal Data System (USRDS - a large epidemiological dataset) to explore the evolution of gout burden (including gout flares, emergency room visits related to gout, and gout hospitalizations) in patients with gout progressing from advanced CKD to dialysis, and for those undergoing kidney transplant. We believe the transition period into dialysis and then into kidney transplantation is a critical time for worsening of gout outcomes, and is also associated with cardiovascular events such as myocardial infarction.